Health-related quality of life and patient reported outcomes among people living with HIV and cancer

PROJECT SUMMARY
Advances in HIV treatment have improved life expectancy among people with HIV (PWH). As PWH live longer,
they are at increased risk for cancer and cancer-related mortality compared with the general population.
However, it remains unclear what factors may contribute to persistent survival disparities and poor cancer
outcomes among PWH in the US. Integrating measurement of patient-reported outcomes (PROs) into routine
and supportive cancer care is a potential strategy to improve PWH’s quality of life, cancer outcomes, and survival.
PROs encompass data reported directly by patients to describe how they feel and function, such as symptoms,
physical function, and health-related quality of life. In the general (i.e., HIV-uninfected) cancer patient population,
PRO scores are associated with several adverse cancer clinical outcomes including poor response to therapy,
cancer progression, and shorter survival. Given that PWH are also more likely to be diagnosed with non-AIDS
defining cancers at later stages and experience elevated mortality, it is urgent to investigate opportunities, such
as the role of PROs, to improve survival and ultimately reduce preventable cancer deaths among PWH. However,
to our knowledge, no research exists in the context PROs and overall health-related quality of life among PWH
with cancer. To address this research gap, our objective is to evaluate physical and mental health symptomology
(PROs) throughout the cancer diagnosis trajectory and associations with cancer outcomes among HIV-positive
cancer patients. We propose a two-pronged approach: we will leverage an existing, NCI-sponsored, data linkage
between the Surveillance, Epidemiology, and End Results (SEER) cancer registry data and Centers for Medicare
and Medicaid Services (CMS)’ Medicare Health Outcomes Survey (MHOS) (Aims 1 and 2) and conduct primary
data collection among HIV positive cancer patients treated at an NCI-designated cancer center (Aim 3). We will
carry out the following specific aims: Aim 1: Compare changes in patient reported outcomes (PROs) after a
cancer-diagnosis among non-AIDS defining cancer patients living with and without HIV; Aim 2: Estimate
associations of PROs (pre-diagnosis, post-diagnosis, and change in PROs) with overall survival among older
patients diagnosed with non-AIDS defining cancers with HIV; and Aim 3: Explore the role of HIV-specific clinical
and social factors in patient reported outcome assessments among a broad age range of HIV positive cancer
patients treated at one NCI-designated cancer center. Findings from this research will provide preliminary data
to inform the development of future large-scale R01-level research opportunities focused on improving symptom
control among PWH with cancer and evaluating the integration of tailored patient-reported outcome data
collection into routine supportive care of this vulnerable population.

Public health relevance
PROJECT NARRATIVE People with HIV (PWH) with a cancer diagnosis experience elevated cancer-specific mortality and worse cancer outcomes compared to their HIV-negative counterparts. Poor symptom management may contribute to lower survival among PWH with cancer, however, limited research exists evaluating patient-reported outcomes (PROs). By utilizing an existing unique linkage stewarded by the NCI called SEER-MHOS complemented by primary data collection characterizing PROs and related HIV-specific social barriers among HIV positive cancer patients treated at an NCI-designated cancer center, the current study will explore PROs among cancer patients with HIV to inform the development of future large-scale R01-level research opportunities focused on improving multi-faceted symptom control among PWH with cancer to ultimately reduce preventable cancer deaths among U.S. PWH.